Calcineurin signaling cascades governing Cryptococcus virulence

Abstract Cryptococcus is one of the most important HIV/AIDS-associated pathogens, causing >220,000
infections, >180,000 deaths, and >15% of all HIV/AIDS-related deaths annually. The ability of C. neoformans to
survive at mammalian body temperature and in the presence of other host stress conditions is essential for
virulence. We identified the protein phosphatase calcineurin as a major molecular determinant required for
Cryptococcus thermotolerance and virulence. In response to temperature stress, calcineurin is activated by Ca2+-
calmodulin and acts as a serine/threonine phosphatase. Calcineurin plays broad roles in cryptococcal virulence
and is necessary to survive heat, cation, alkaline, and cell wall stress. We have further demonstrated calcineurin
plays conserved roles in virulence of other human pathogenic fungi (Candida, Aspergillus, Mucor), and others
have shown calcineurin is critical for virulence of Leishmania, Plasmodium, and plant fungal pathogens.
However, calcineurin is conserved across eukaryotes, and calcineurin inhibitors are potent immunosuppressants
in humans and thus difficult to utilize as antifungal drugs. Studies are in progress developing less
immunosuppressive analogs as candidate therapies. Thus, calcineurin is a general, conserved virulence factor
in eukaryotic microbial pathogens that can be targeted for therapy, and elucidation of the roles and mechanisms
of calcineurin signaling cascades can identify fungal-specific targets and is of general importance.
We have achieved several key advances elucidating calcineurin roles in Cryptococcus pathogenesis. We
discovered heat and other stresses induce calcineurin to re-localize from the cytoplasm to P-bodies/stress
granules, sites of mRNA post-transcriptional/translational control. Via phospho-proteomic studies, we identified
calcineurin targets including the transcription factor Crz1 and proteins that localize to P-bodies/stress granules
and mediate mRNA processing, stability, and translation. Additionally, we identified stress-response genes
regulated by calcineurin-Crz1, as well as mRNAs regulated by calcineurin but not Crz1 through RNA-seq
analysis. These findings support our hypothesis that calcineurin controls a bifurcated signaling cascade
promoting stress survival and pathogenesis. In one branch, calcineurin stimulates Crz1 nuclear localization
and gene expression promoting stress survival and virulence. In a second, less-studied branch, calcineurin
undergoes heat-induced re-localization to P-bodies/stress granules and acts on targets governing mRNA
processing, stability, and translation, promoting pathogenesis post-transcriptionally. We propose two aims to test
this hypothesis. In Aim 1, we will identify, validate, and characterize high temperature specific calcineurin
interactors as substrates and effectors via TurboID-proximity labelling and Crz1 ChIP-seq analysis. In Aim 2, we
will define the importance of calcineurin re-localization and action on P-body/stress granule targets that enable
Cryptococcus to surmount host stress and infect normal and immunocompromised hosts. These studies will
elucidate conserved stress-responsive virulence networks of eukaryotic pathogens as therapeutic targets.

Public health relevance
NARRATIVE The goal of this proposal is to elucidate calcineurin-signaling cascades governing stress responses and virulence of the human fungal pathogen Cryptococcus, which has a significant global public health impact and infects both immunocompromised (HIV/AIDS, transplant recipients, and others) and immunocompetent individuals to cause life-threatening diseases of the lungs and brain (pneumonia, meningoencephalitis). Combined, Cryptococcus species are responsible for >220,000 infections each year and more than 181,000 deaths worldwide, resulting in >15% of all HIV/AIDS-associated deaths. The studies proposed will 1) identify and characterize novel calcineurin-interacting proteins and study these as short- and long-term effectors of stress-responsive virulence pathways, and 2) define the roles of calcineurin re-localization to P-bodies/stress granules during stress in operating a bifurcated stress-response pathway required for pathogenesis.